Chromosomal instability as a driver of non-small cell lung cancer immune evasion and brain metastasis

PROJECT SUMMARY/ABSTRACT
Brain metastasis (BM) frequently arises from non-small cell lung cancer (NSCLC) and represents the most
common cause of cancer related death in the US, yet our understanding of BM biology is rudimentary. Our group
has recently identified excessive chromosomal instability (CIN) as a hallmark of BM19. In in vitro studies, in
addition to validation in multiple independent NSCLC patient datasets (TCGA, GENIE, CCLE, and CPTAC)
detailed in this proposal, we have identified CIN as a hallmark of NSCLCs harboring mutations in STK11
(encoding LKB1). LKB1-deficient NSCLCs are an aggressive tumor subtype associated with increased risk of
BM and immunotherapy resistance, and thus serves as a relevant archetypical disease that may broadly inform
the role of CIN in BM biology and cancer immune evasion. CIN arises from failures in correct chromosome
segregation during mitosis, leading to perpetual gains and losses of chromosome arms and the creation of
rupture-prone micronuclei. Upon rupture, these micronuclei expose DNA to the cytosol, activating cGAS-STING
signaling. This would seemingly present a conundrum for CINhigh cancers, as prototypical outputs of cGAS-
STING activation promote anti-tumor type I interferon (IFN) responses. However, it has been recently shown
that chronic cGAS-STING signaling characteristic of CINhigh tumors promotes metastatic non-canonical NF-kB
output, in addition to immune-evasive adenosine generation in the tumor microenvironment, the latter
accomplished through adaptive increases in cGAMP export and upregulation of surface ectonucleotidases
ENPP1 and NT5E. In addition to its ability to promote immunosuppression, adenosine also permeabilizes the
blood brain barrier and thus may potentially mechanistically link BM to CIN. This proposal seeks to understand
how cancer cell adaptations to CIN enable BM and immune evasion, namely through investigation of tonic
activation of cGAS-STING signaling. In Aim 1, I propose to delineate the respective contributions of CIN and
LKB1 loss per se to metastatic behavior and immunotherapy resistance in vivo. In Aim 2, I will perform spatio-
temporal resolved in vivo studies to delineate CIN-intrinsic (i.e., STING signaling) and -extrinsic (e.g. adenosine
generation) interactions that enable immune evasion and BM. Through generation of genetic perturbations in
LKB1-deficient and WT models, I will investigate whether chronic cGAMP-triggered STING recycling is a
hallmark of CINhigh, LKB1-deficient NSCLC that favors immune-evasive tumor behavior and establishment of BM.
Together, these aims offer unparalleled study of interactions critical for the establishment of the brain metastatic
niche and will pave the way for therapeutic development of malignant, treatment-resistant CINhigh tumors. With
the guidance from exceptional mentors and collaborators and access to the unparalleled scientific research
environment at Columbia University Irving Medical Center, this project will prepare me for a successful career
as a physician-scientist in the field of cancer biology.

Public health relevance
PROJECT NARRATIVE Brain metastasis (BM) frequently arises from non-small cell lung cancer (NSCLC) and represents the most common cause of cancer related death in the US, yet our understanding of BM biology is rudimentary. Our group has identified excessive chromosomal instability (CIN) as a hallmark of BM and as a putative characteristic of NSCLCs harboring mutation in STK11 (encoding LKB1), a subtype of lung cancer associated with increased risk of brain metastasis (BM) and immunotherapy resistance, and thus a relevant archetypical disease that may broadly inform the role of CIN in BM biology. This proposal seeks to identify tumor-cell intrinsic and extrinsic adaptations to CIN that enables immune evasion and BM in LKB1-deficient NSCLCs; because CIN is pervasive in cancer and particularly high in brain-metastatic lesions across different cancer types, this work will have implications for our broader understanding of BM biology and pave the way for future therapeutic development of CINhigh tumors.